Enhanced Antibody-Dependent Cellular Cytotoxicity in HIV Vaccine by Novel Adjuvant

PROJECT SUMMARY
This exploratory study addresses the challenge of developing an effective HIV vaccine by focusing on natural
killer (NK) cells and their ability to mediate antibody-dependent cell-mediated cytotoxicity (ADCC). Building on
the RV144 vaccine regimen, which demonstrated some efficacy in preventing HIV infection, the study explores
using a novel oral adjuvant to enhance NK cell cytotoxicity and ADCC activity in the nonhuman primate model.
Preliminary studies in a murine model showed promising results with this adjuvant, leading to the expansion of
KLRG1+ NK cells known for their ADCC capacity. The study aims to investigate phenotypic, functional, and
molecular changes in NK cell subsets in various tissues following RV144-like vaccination with the novel adjuvant.
Additionally, the research aims to assess the enhanced antiviral effects and increased ADCC capability of NK
cells induced by the combined vaccine and novel adjuvant. This innovative approach seeks to discover a novel
vaccine adjuvant that strengthens NK cell activity against SIV/HIV in different tissues, potentially advancing the
development of preventive HIV vaccines and therapeutic interventions.

Public health relevance
Project Narrative This study explores the use of a novel oral adjuvant in conjunction with the RV144 vaccine regimen to enhance natural killer (NK) cell cytotoxicity and antibody-dependent cell-mediated cytotoxicity (ADCC) activity. Inspired by promising results in murine models, the research aims to investigate changes in NK cell subsets across tissues and assess the combined vaccine and adjuvant's impact on antiviral effects. The innovative approach seeks to uncover a potential vaccine adjuvant that strengthens NK cell activity against SIV/HIV, advancing efforts in preventive HIV vaccine development.